Vestibular Implantation to Treat Adult-Onset Bilateral Vestibular Hypofunction

Project Summary
Bilateral loss of vestibular sensation is disabling, with affected individuals suffering chronic disequilibrium,
increased risk of falls, and inability to maintain stable vision during head movements typical of daily life. While
most individuals with milder loss compensate through rehabilitative strategies enlisting other senses, those
with severe loss who fail to compensate have no good therapeutic options. When the vestibular nerves are
anatomically intact, as is true in most such cases, electrical stimuli encoding head rotation can drive nerve
activity and partially restore vestibular sensation, much as a cochlear implant partially restores auditory
sensation. In an on-going first-in-human early feasibility study of six adults disabled by bilateral vestibular
hypofunction after ototoxic hair cell injury, we found that vestibular implantation and motion-modulated
prosthetic stimulation targeting the implanted ear's three semicircular canals is a feasible, safe and effective
treatment for ototoxic loss, as evidenced by directionally-aligned vestibulo-ocular reflexes reliably elicited
during >3 years of continuous use, improvements in objective measures of posture and gait performance, and
improvement of patient-reported dizziness handicap and vestibular-related disability. On the strength of those
results, the United States Food & Drug Administration (FDA) has invited a request for humanitarian device
exemption for treatment of ototoxic loss; however, FDA advised that additional data would be required to
support expanding availability of this treatment to individuals with idiopathic loss, who make up the largest
proportion of bilateral vestibular hypofunction cases. Drawing on a well-established design, intact study team,
and protocol that yielded highly impactful results in the early feasibility study of subjects with ototoxic loss, the
proposed research program will extend this approach to adults disabled by idiopathic adult-onset bilateral
vestibular hypofunction. Results of this research are highly likely to yield broad, sustained impact, either
through support of early regulatory approval (if results of vestibular implantation for treatment of idiopathic loss
are as favorable as the results already obtained for ototoxic loss) or by providing the necessary foundational
data to support design of a subsequent, large-scale pivotal trial of vestibular implantation for idiopathic loss.

Public health relevance
Project Narrative Severe bilateral loss of vestibular sensation – the inner ears' sense of balance – causes chronic dizziness, blurry vision during head movement, a constant need to exert conscious effort to do things that are normally automatic (like walking without wobbling or falling), and inability to drive or swim safely. In an already FDA- approved and actively recruiting first-in-human trial, we have recently shown that a vestibular implant that senses head motion and artificially stimulates the vestibular nerve – much like the way a cochlear implant helps treat people with severe hearing loss – helps to improve the signs and symptoms of bilateral vestibular loss caused by medicines that are sometimes toxic to the inner ear. The research project we now propose will (1) determine whether a vestibular implant can help the nearly 1 million adults disabled by bilateral vestibular loss that is idiopathic (has no identified cause); (2) assess the long-term safety and effectiveness of vestibular implants by supporting and tracking the performance of the pioneering subjects already implanted; (3) lay the groundwork for the first pivotal multicenter trial of vestibular implantation; (4) help ensure that vestibular implantation is available at centers in the United States; and (5) create a solid foundation from which vestibular implantation can grow, as did cochlear implantation, to become a routine and effective treatment, a robust and diverse field of clinical investigation, and a technology that opens new lines of scientific inquiry into how the inner ear and brain work together to help you see clearly, walk automatically, and focus your thoughts on where you are headed and why rather than on how to avoid falling on your way there.